A Model Editing Framework for Participatory Multimodal AI in Dermatology

Abstract (250 Words)
Multimodal artificial intelligence (MAI) systems hold significant promise for improving diagnostic
accuracy in diverse clinical domains, particularly in dermatology, where various data sources
such as clinical images, dermoscopy, pathology, and text are integral to diagnosis. However,
stakeholders, including clinicians, have minimal involvement in the development of medical AI,
which are often entirely designed and deployed by engineers as “black-box” systems. This
opaque and one-way approach to AI deployment hinders accountability and lacks a feedback
mechanism for stakeholders to correct AI errors. In dermatology, where single-modality AI often
struggles with spurious correlations and lack of training data for underrepresented patient
groups, the adoption of multimodal models raises concerns about exacerbating these errors and
biases. To address this, we propose "Participatory MAI" for skin disease—a framework for
co-design in which dermatologists directly intervene in MAI models to correct errors throughout
their deployment. Our approach involves developing MAIs with novel editability capabilities
that enable stakeholders to apply explicit modification to the MAI behavior using interpretable
natural language instructions. The project will contribute new methods, models and
datasets for Participatory MAI in dermatology. It will deliver (1) the first algorithms for
multimodal model editing, (2) a proof-of-concept editable MAI for skin disease
(DermaCLIP), and (3) a first publicly-accessible multimodal dataset for dermatology
(Multi-Skin) alongside a pilot study evaluating our Participatory MAI approach. Integrating
editing capabilities into MAIs marks a shift from opaque data-driven fine-tuning to transparent
participatory fine-tuning under human oversight. Outcomes of this project are widely applicable
across various clinical domains and modalities.

Public health relevance
The proposed research is relevant to public health because it will develop new methods that enable highly-skilled dermatologists to edit multimodal AI models to achieve dermatologist-level performance in diagnosing skin disease. This would enable primary care physicians in under-served and rural areas in the U.S. to use multimodal AI models to assist in making referral decisions for patients with skin disease using multiple imaging modalities such as clinical photography and dermoscopy. The project proposes a participatory framework to achieve this goal by developing model editing methods that enable dermatologists to fix the outputs of multimodal AI models using feedback expressed in accessible natural language.